EPIDEMIOLOGY OF ROTAVIRUS INFECTIONS IN BANGLADESH

This project tests the hypothesis that humoral immunity to rotavirus infection, assessed in serum, is associated with the risk of rotavirus diarrhea in children aged under 2 years who reside in rural Bangladesh. Cases of rotavirus diarrhea were assembled from population-based, comprehensive surveillance of treated episodes of pediatric diarrhea in Matlab, Bangladesh during 1985-86. All rotavirus diarrhea episodes were serotyped with monoclonal antibodies after cultivating rotavirus isolates. Controls were similarly aged childred randomly selected during four surveys of the Matlab community undertaken during 1985-86. Serological correlates of natural immunity to rotavirus diarrhea were assessed by contrasting acute-phase sera collected from the cases and sera from controls. Case-control comparisons revealed that: 1) serum IgG antirotavirus antibodies were correlated inversely with the occurrence of rotavirus diarrhea, suggesting a protective relationship; but 2) protective associations were not serotype-specific. As a second goal, we sought to determine A whether breast feeding is associated with a reduced risk of rotavirus diarrhea in children under the age of 2 years. Comparisons of cases and community controls for antecedent histories of breast feeding revealed that: 1) breast feeding was associated overall with a reduced risk of rotavirus diarrhea, due to the protection conferred by exclusive but not partial breast feeding; but 2) after infancy, the direction of the relationship became reversed, with a higher risk of rotavirus diarrhea among breast-fed than non-breast-fed children.